Mechanism of RAD51C fork protection and environmental carcinogenesis

SUMMARY
Environmental carcinogens generate DNA damage that stalls DNA replication. This jeopardizes genomic
integrity critical to diverse disease-suppression. Accumulating reports show that individuals with mutations in
breast cancer predisposition genes (BRCA) (found in more than 1 in 150 people) have increased cancer rates
upon exposure to environmental carcinogens. The underlying cause for this has recently come under debate.
In this application, we will determine the molecular mechanism of DNA replication fork protection (FP)
mediated by BRCA3/RAD51C and how RAD51C and FP suppress carcinogen-induced tumorigenesis.
RAD51C is the newest and perhaps least understood member of the BRCA disease suppressor family.
Because of sequence homology to RAD51, which is regulated by BRCA1/2 during homology-directed double-
strand (DSB) break repair, RAD51C studies have focused on its repair function. However, patient data
suggests an additional tumor suppression function; 8 out of 10 disease-linked RAD51C patient mutations
initially identified, do not cause DSB-repair deficiencies and based on this were designated unclassified. Yet,
multiple subsequent independent breast cancer population studies identified the same alleles, suggesting
significance for disease penetrance. BRCA genes have cellular functions besides DNA repair. Importantly, this
includes the protection of stalled DNA replication forks from degradation by MRE11 nuclease, a new functional
pathway that we have recently defined. Excitingly, our preliminary data shows many of the unclassified cancer-
associated RAD51C mutations compromise FP, irrespective of DSB-repair. FP prevents genome instability
ubiquitously at stalled DNA replication forks as induced by virtually all environmental carcinogens. We thus
hypothesize that BRCA3/RAD51C safeguards against environmental carcinogens through protection of stalled
DNA replication forks. In Aim 1) we will define the mechanism of RAD51C mediated fork stability, enabled
by our discovery and understanding of new BRCA gene functions in FP, by our development of a single-cell
assay for protein-DNA replication fork interactions (SIRF), by our structural understanding of the RAD51C DNA
binding and ATPase domains and by having established CRISPR/CAS9 knock-in mutant RAD51C human cell
lines. In Aim 2) we will determine if FP defects promote environmental carcinogen-induced mammary
tumorigenesis in vivo, enabled by our having established a viable mutant RAD51C mouse model with FP
defects, but no apparent DSB-repair defects, and by our understanding of genetic control of FP and DSBs by
PTIP and 53BP1, that allows us to genetically test and distinguish FP from DSB repair contributions to
carcinogen-induced mammary carcinogenesis. Collectively the proposed research will provide fundamental
knowledge of how RAD51C-mediated FP suppresses environmentally induced genome instability and tumors.
As many genes besides BRCA genes are now known to control FP, the outcome of our studies can have
important broad implications for accurate and efficient disease-risk assessment for a large group of people.

Public health relevance
PROJECT NARRATIVE Environmental carcinogens halt DNA replication by damaging DNA and so jeopardize genome integrity critical for tumor and disease suppression. Accumulating reports show individuals with mutations in breast cancer (BRCA) predisposition genes have increased risk for disease upon exposure to environmental carcinogens, albeit the underlying cause is recently under debate. In this application, we propose to determine BRCA3/RAD51C functions in the newly defined DNA replication fork protection pathway and DNA fork protection contributions to suppression of carcinogen-induced tumorigenesis in vivo.